New Catalysts and Strategies for Selective C–H Functionalization and Cycloaddition Reactions

Project Summary/Abstract
Organic synthesis is a rate-limiting factor in drug discovery, and consequently, advances in synthetic methods
relevant to bioactive molecule preparation can be a powerful driving force to accelerate the discovery of new
small molecule therapeutics for unmet medical needs. Research in the Hilinski laboratory is focused on
addressing unsolved challenges in catalysis and synthesis that have immediate relevance to the contemporary
practice of drug discovery, and that have the potential for broad impact as widespread platforms for new reaction
discovery and/or synthetic planning. We are also invested in the direct application of small molecule synthesis
to drug discovery, in collaborative projects that use small molecules to engage new biological targets for cancer
treatment. This MIRA application outlines our recent endeavors and future plans in two areas: (1) catalytic,
selective C–H functionalization, and (2) novel cycloaddition reactions. In the first area, research in the field of
intermolecular, site selective C(sp3)–H hydroxylation and amination has advanced considerably in recent years,
but has reached a major barrier in the desire to transition from substrate-controlled selectivity to catalyst
controlled selectivity. To address these and other challenges, we have established a program in organocatalytic
atom-transfer C–H functionalization and over the past several years have shown that our catalytic platform,
focused on iminium salt and amine catalysts, competes with or exceeds metal-catalyzed methods in reactivity
and selectivity, and also that it has the flexibility to enable multiple types of atom transfer (i.e. both hydroxylation
and amination). Having established this foundation, we are now beginning to better understand the unique
mechanistic details of these reactions and the influence of catalyst structure on reactivity and selectivity. Our
goals over the next five years are to use amine catalysis to override substrate control of C–H hydroxylation site
selectivity and to develop enantioselective C–H hydroxylation methods, and to use iminium catalysis to expand
both the scope and selectivity among benzylic, unactivated tertiary, and unactivated secondary C–H bonds in
late-stage C–H amination applications. Distinct from our research on C–H functionalization, we have also
established a program on the invention of new regioselective and stereoselective cycloaddition reactions
targeting nitrogen-containing heterocycles and carbocycles appended to nitrogen-containing heterocycles, two
major structural motifs in drug discovery. Described in this application is our recent discovery of Lewis acid
catalysis of a virtually unexplored variant of the Diels-Alder reaction – one that uses vinylazaarenes as
dienophiles. Over the next five years, we intend to pursue our long-term goal of establishing this as a strategy-
level synthetic approach by expanding this chemistry to include hetero Diels-Alder reactions to form azaarene-
appended aliphatic nitrogen heterocycles, and by developing enantioselective variants. The results of these
future research plans will enable an expansion of the chemical space that can be explored for drug discovery.

Public health relevance
Project Narrative This research aims to develop new chemistry that will be useful to the synthesis of potential pharmaceuticals. The understanding of this new chemistry and the optimization of the desired reaction outcomes will expand the types of structures of potential drugs that chemists can synthesize, thereby increasing the chances of success in developing new classes of drugs for unmet medical needs.